In vivo monitoring of tumor microenvironment regulation for macrophages

Hypoxia and macrophages drive tumor aggressiveness and treatment outcome leading to worse prognosis for
breast cancer patients. Contrary to acute hypoxia where tissue homeostasis is vital for development and repair,
chronic hypoxia observed in solid tumors stimulate unproductive angiogenesis by excessive vascular endothelial
growth factor expression leading to dysfunctional vessels that perpetuate hypoxia and acidic extracellular
pH; factors that limit effective perfusion of treatment modalities like chemotherapies and radiotherapies and
promote tumor aggressiveness. Macrophages are intimately involved in regulating unproductive angiogenesis
thru secretion of soluble factors that support this activity. In the parent grant, we advanced electron paramagnetic
resonance (EPR)-based techniques towards in vivo real-time tumor microenvironment (TME) profiling in animal
cancer models. Using these approaches, we showed macrophage hypoxia-inducible transcription factors (HIF)-
1α and HIF-2α had disparate roles in regulating TME parameters like oxygen and pHe through structural and
functional alterations in vessels that dictated docetaxel efficacy. We showed that HIF-1α augments expression
of endothelial tyrosine kinase (TIE2) receptor on macrophages called TIE2-expressing macrophages (TEMs)
previously-reported to be “pro-angiogenic”, but now better defined as “pro-hypoxic” by dysregulating vessels
leading to poor perfusion. The overall objective of the renewal is to investigate macrophage location and function
that perpetuates a hypoxic TME detrimental to perfusion of therapeutic modalities. To achieve this central
objective, we propose these specific aims: (SA1): To optimize magnetic resonance imaging modalities for
in vivo multifunctional mapping of local tumor tissue parameters. Advances in paramagnetic probes and
imaging technologies such as rapid scan EPR imaging and Overhauser-enhanced MRI allow for mapping
specific areas of hypoxia and acidosis and characterizing their relationship to tumor macrophage locoregional
populations. (SA2): Elucidate tumor macrophage location-specific functions in regulating hypoxia and
acidosis in a mouse model of breast cancer. We will sample tumor origin and regions of hypoxia in PyMT
breast cancer models using image-guided biopsy to understand the bi-directional shaping of TME and
macrophages that contribute to poor vessel perfusion and hypoxia. (SA3): Investigate recruited and tissue-
resident macrophage populations and their respective roles in contributing to tumor hypoxia and
acidosis that dictate chemotherapy effectiveness. We will track fluorescent bone marrow monocytes to tumor
origin, and generate conditional macrophage-deficient breast tumor mice to systematically determine a causal
role of specific macrophage populations. Summarizing, in vivo mapping of tumor hypoxia and acidosis using
innovative magnetic resonance technology in mice deficient in specific macrophage populations or lacking
hypoxia-regulated macrophage functions in a mouse model of breast cancer may provide new insight into a
macrophage/TME axis that suppresses the efficacy of clinically-relevant anti-cancer therapies.

Public health relevance
PROJECT NARRATIVE This project aims to test the hypothesis that bi-directional interaction between tumor microenvironment and region-specific macrophages plays a role in tumor progression thru regulation of hypoxia and acidosis. In vivo mapping of tumor hypoxia using innovative magnetic resonance technology in mice deficient in specific macrophage populations or lacking hypoxia-regulated macrophage functions in a mouse model of breast cancer may provide new insight into a macrophage/tumor microenvironment axis that suppresses the efficacy of clinically-relevant anti-cancer therapies.